COMPUTERIZED THERMOGRAPHY OF CRANIOMANDIBULAR DISORDERS

Today, facial heat emission patterns may be rapidly obtained and quantified using advanced electronic thermography units and new computer programs which have promise of being non-ionizing, non-invasive, low cost, diagnostic alternative for evaluation of craniomandibular disorders, as compared to current diagnostic examinations which use ionizing radiation (plain and tomographic x-ray examinations), expensive technology (CT and MR imaging), or invasive techniques (arthrotomography of the TMJ). Hypothesis to be tested in this diagnostic study: 1. Thermography as a diagnostic test interpreted by experts in blinded trials will be able to distinguish between normal subjects and patients having internal derangements, osteoarthritis, or arthralgia of the TMJ; 2. Computer measurements made using facial thermograms will be able to distinguish between normal and diseased patient populations (internal derangements, osteoarthritis, and arthralgia of the TMJ); 3.Computer measurements will be superior to thermography experts making diagnostic decisions from the same patient thermograms. Design and methods: Target study populations will consist of 4 groups; patients having internal derangement, osteoarthritis, or arthralgia of the TMJ, and normal subjects. Thermography Equipment. Agema 880 thermovision unit; including an infrared scanner control unit, and thermal image computer TIC-8000. Facial Imaging. Right, left; lateral, and frontal thermograms are to be taken on 120 subjects a photographed for diagnostic evaluation. Computerized Image Analysis. Mathematical analysis will be made from electronic images using TIC-8000 computer and color monitor. Diagnostic Image Assessment. Evaluations will be made in single-blind fashion, independently by 2 examiners, using correct classification rates (sensitivity, specificity). Data Analysis; will include calculating linear discriminent scores from the set of computer measurements for each of the 4 groups. In addition, true-positive and false-positive rates for the observers and the linear discriminant scores will be compared for all diagnostic studies.